DMS/NIGMS 2: Bayesian modeling of single cell spatial transcriptomics data to identify significant spatial

Physiological processes such as the sleep-wake cycle, metabolism, hormone secretion,neuro transmitter release,
sensory capabilities, and a variety of behaviors including sleep, aggression, and mating are controlled by a circadian
rhythm adapted to 24h day-night periodicity. The suprachiasmatic nucleus (SCN), which is in the anterior
hypothalamus, controls the physiological responses in vertebrates. The peripheral tissues such as liver, heart, kidney,
and mammary glands contain functional endogenous glands. SCN influences both the peripheral clock (which
regulates numerous physiological processes including proliferation and apoptosis) as well as the central clock via a
combination of neural and hormonal signals. Several epidemiological studies revealed that circadian rhythm
disruption (CRD) impacts human health and increases the risk of developing metabolic disorders, cardiovascular
diseases, and mood disorders. As the exact molecular mechanisms by which CRD alters mammary microenvironment
are not known, therefore, in this study we propose to leverage the strength of next-generation sequencing and
statistical bioinformatics approaches by performing single–cell spatial proteomics of the studied samples. We
hypothesize using this high throughput technique will not only give an unbiased global and complete view of the
cellular activities but will also provide pivotal insights about the affected cellular pathways. Using spatial
transcriptomics, we will measure gene expressions at the single cell level along with the information of spatial
locations of these cells in the tissue. In spatial transcriptomics, the gene expression data, along with spatial co-
ordinates of the single cells, provides information on both gene expression significance and cell spatial dependencies.
We propose flexible Bayesian approaches to investigate how CRD affects cell composition of a tissue by using
spatial clustering algorithms to the spatial transcriptomic data. Next, after obtaining the cell types we will identify
the cell-type-specific spatially varying genes. These will be utilized to see the effect of CRD disorder in gene and
cell levels. The proposed research is targeted to single cell spatial transcriptomics; however, the derived methods and
the results will have deep impact on the research fields of Bioinformatics and data science. Finally, computationally
efficient, and tractable software (R/Python) packages will be developed, will be delivered and will be regularly
updated to maximize impact across both statistics and medicine. The proposed research has immense transformative
potential in the areas of basic cell and development biology, and single cell bioinformatics. It will bring together
researchers from multiple disciplinary areas to conduct research on these fundamental themes.
RELEVANCE (See instructions):
The proposed research will provide critical answers as to whether circadian disruption via shift-work or traveling
across the zones can impact mammary gland development and set the stage for further investigation of the underlying
mechanisms. This study will lead to a better understanding of how circadian rhythm disruption (CRD) interrupts cell-
cell interaction during different developmental stages using the data from single cell transcriptomic technique and will
identify the key genes.